PhonBank integration within TalkBank: Acquisition, disorders, dysfluencies and paraphasias

This project integrates five NIH-supported components of TalkBank by linking
phonological codes from PhonBank, fluency codes from FluencyBank and lexical and
grammatical codes from CHILDES, AphasiaBank, and DementiaBank. This integrated
database will give us an improved way of studying profiles in various language disorders
and types of development.

Public health relevance
The goal of this project is to provide better ways of understanding relations between the different domains or levels of language in language disorders and language development. To do this, we will provide complete phonological and fluency annotations of 200 transcripts taken from the databases for aphasia, dementia, child language disorders, and childhood disfluency. We will improve the capacity of the Phon program and the TalkBankDB database search system to operate with data across these different data types. This will allow us to conduct analyses of patterns that consider relations between the different language domains of phonology, fluency, lexicon, grammar, and discourse. These patterns will also be captured through analyses that seek to align the profiles of individual participants with comparison groups from the larger database.